Exercise-induced Legacy Health Benefits on Cardiometabolic Risk Factors in Aging Adults with Prediabetes

Abstract
Exercise training produces substantial health benefits, summarized in the Physical Activity Guidelines Advisory
Committee Report and incorporated into the 2008 and 2018 Physical Activity Guidelines for Americans.
Despite the well-known benefits, too few individuals adopt exercise as a health maintenance strategy. Thus,
determining whether a relatively modest duration of exercise training in middle age can lead to sustained
health benefits as individuals progress into older age groups (legacy effects) is of public health and clinical
importance. In previously sedentary, overweight middle-aged adults with dyslipidemia, our STRRIDE I
Reunion study revealed legacy effects for fitness and cardiometabolic risk factors 10 years following exercise
intervention; some of these effects were specific to the amount and intensity of exercise performed. In light of
the legacy benefits observed in STRRIDE I, the proposed STRRIDE-PD Reunion study seeks to determine the
extent to which changes in fitness and cardiometabolic risk factors acquired in individuals aged 45-75 are
maintained over a 10-year period in participants from the STRRIDE-Prediabetes (STRRIDE-PD) randomized
trial. Importantly, the STRRIDE-PD Reunion will allow us to verify the observed legacy effects of aerobic
exercise training in participants at greater risk for cardiometabolic disease. The STRRIDE-PD trial included a
group similar to the lifestyle arm of the Diabetes Prevention Program, designed to achieve weight loss through
diet and exercise. This unique design element will allow us to compare the ability of different aerobic exercise
interventions – with and without weight loss – to elicit sustained cardiometabolic health benefits in adults with
prediabetes. Combined with the previous STRRIDE studies, the STRRIDE-PD Reunion will solidify the
scientific knowledge exploring the underlying molecular mechanisms by which exercise – differing in amount,
intensity, and mode – produces sustained health benefits across the lifespan from age 45 to 85. Overall,
findings from this research will demonstrate the power and value of exercise training programs of even modest
duration to elicit long-term cardiometabolic health benefits.

Public health relevance
Project Narrative In medicine, the sustained benefit of a treatment long after cessation of the intervention is termed a legacy effect. As exercise produces substantial health benefits following intervention, this proposal seeks to determine the legacy health benefits of exercise intervention in middle-aged adults and uncover novel pathways by which these exercise-induced legacy health effects occur. Findings from this project will help guide personalized exercise medicine for both short-term clinical needs and long-term health maintenance as individuals age.